Developmental Impacts of Sleep on Positive Valence Systems and Socioemotional Functioning during Pre-Adolescence

Project Summary
Sleep patterns characterized by truncated weekday sleep followed by weekend recovery sleep (‘social jetlag’)
often begin to emerge during pre-adolescence (8-12 years). Research from our team has demonstrated that
this sleep pattern adversely impacts positive valence systems (PVS) in ways that elevate risk for depression
and other psychiatric disorders. Heightened neuroplasticity and re-organization of reward-related brain regions
present during this period of the lifespan likely confer a unique opportunity for prevention and intervention, but
research on sleep-affective relations during this vulnerable period of development remains limited. The present
set of studies will examine mechanistic pathways between behavioral and neurophysiological (EEG) sleep
patterns and PVS in social and non-social contexts during pre-adolescence. Study 1 includes an intensive one-
year longitudinal burst design with a non-clinical sample of youth (N = 290; ages 8-12). At three separate
assessment waves (6 months apart), participants will complete a 14-day monitoring period including objective
sleep using actigraphy, daily video diaries and surveys, passive audio recordings of naturalistic social
interactions, and a series of behavioral tasks to assess reward responsiveness, learning, and valuation. This
longitudinal study is complemented by Study 2, which includes a separate sample of non-clinical youth (N =
64; ages 10-12) who will complete an experimental protocol using a randomized crossover design. Participants
will stay in the laboratory with a friend for two 5-night visits where dyads will simultaneously undergo multiple
nights of sleep restriction followed by recovery sleep, as well as 5 nights of healthy sleep. Each evening in the
lab, participants will complete surveys and paradigms assessing social and non-social reward responsiveness,
learning, and valuation. A daily recorded interaction period with their peer will also be coded for positive social
behaviors (approach behaviors, affective synchrony, positive affective expression, and gaze patterns using eye
tracking). Participants will also complete polysomnography during each night of the laboratory protocols and
changes in sleep EEG (i.e., rapid eye movement sleep) will be examined as a mechanism underlying daytime
socioemotional changes. Additional analyses for both studies focus on how biological sex modifies
socioemotional vulnerability to sleep patterns. The proposed research addresses multiple critical gaps in
scientific knowledge surrounding the impact of sleep on the development of reward systems and social
functioning during pre-adolescence. Specific aims leverage RDoC, including PVS and Arousal/Regulatory
systems, and support NIMH’s strategic plan to chart mental illness trajectories and determine when, where,
and how to intervene. Results will inform theories of these neurodevelopmental processes to better inform
prevention and treatment efforts.

Public health relevance
Project Narrative A pattern of shortened weekday sleep and weekend recovery sleep begins to emerge as early as 8 years of age and has been shown to blunt positive emotional experiences, increasing risk for mental health disorders. The present set of studies will provide a mechanistic understanding of how this sleep pattern produces acute and long-term changes in positive valence systems (PVS) in both social and non-social contexts during a period of increased reward sensitivity. Results will provide needed insight into sleep’s role in psychiatric risk during a period of the lifespan marked by rapid changes in socioemotional functioning, including actionable targets for future research and interventions.